Sensorimotor processing in the oculomotor system: moving targets and interceptive saccades

PROJECT SUMMARY
Accurate interception of a moving object presents a significant challenge for the nervous system. The
object’s continuous motion produces a lagged representation of its spatial location in the brain because
retinal signals relayed to motor neurons traverse through diverse parallel pathways with varying integration
times, conduction speeds, and synaptic delays. The brain therefore cannot utilize current retinal signals but
must rely on its ability to estimate the object’s future location. Saccades are an effective motor system to
study interception. The superior colliculus provides an established framework for investigating sensorimotor
processes driving visually guided saccades, but most studies employ stationary targets. In contrast, there is a
dearth of studies on the sensory and motor signatures associated with a moving stimulus and the interceptive
saccade. We intend to fill these gaps in knowledge. We hypothesize that as a target moves through the
visual field, its representation sweeps across the topographic map of visual space in the superior
colliculus. As this population activity interacts with the intra-collicular network, its standard population
activity spatial profile (Gaussian) is altered. We will test this hypothesis using electrophysiological and
computational tools that produce a comprehensive understanding of how target motion affects
sensorimotor activity, at both single-neuron (Specific Aim 1) and population levels (Specific Aim 2). We will
also build a biologically inspired neural network model that simulates superior colliculus activity during
sensation and action phases for both stationary and moving target conditions as well as matches saccade
kinematics (Specific Aim 3). We will then perform a comparative analysis of the intra-collicular connectivity
patterns learned by the model with the findings from previous electrophysiological studies.

Public health relevance
PROJECT NARRATIVE Eye movements provide insights into ocular dysmotility, neuropsychiatric disorders, and mild traumatic brain injury. Considering the greater complexity of sensory to motor transformation required for processing a moving stimulus and intercepting it, clinical deficits may be diagnosed more readily with this behavior.